Novel focused ultrasound enhanced calreticulin-nanoparticle for immune primed melanoma immunotherapy

Summary
Malignant melanoma in advanced stages can be treated with immunotherapeutic antibodies that target CTL-4,
PD1, and PDL1, resulting in enhanced survival rates. However, a large proportion of patients still do not respond
to such therapies due to the presence of immunosuppressive signaling in the tumor microenvironment (TME).
To generate an activated immune microenvironment, our laboratory has developed a liposome-based
nanoparticle (NP) that upregulates calreticulin (CRT) in melanoma TME. Our in vitro and in vivo data in
immunologically cold B16F10 melanoma suggest that intratumoral in-situ vaccination (ISV) with CRT-NP and its
local combination with focused ultrasound (FUS) induce local and systemic immune priming, thereby resulting
in a superior anti-tumor immunity. This is highly promising, but most preclinical studies including ours typically
employ lean mice to investigate immunotherapeutic mechanisms. Risk factors like excess body weight can
exacerbate tumor immunosuppression, but little is known about how CRT-NP efficacy is influenced by this
mechanism, and whether the body mass index of patients should be taken into consideration for designing the
phase I clinical trial. Herein, we will determine the CRT-NP, FUS, and CRT-NP+FUS (CFUS)-based ISV
outcomes in the lean and obese murine models of melanoma. To test our objective, we will first compare the
CFUS local efficacy and immune signaling mechanisms in the B16F10 model (Aim 1). Next, we will combine the
mono- and CFUS therapies with immune checkpoint inhibitors in a clinically relevant YUMM1.7 murine
melanoma (Aim2). The investigation of therapeutic and immune effects in lean and obese mice will enable the
successful optimization of local CFUS in liberating tumors from their immune-suppressive state regardless of the
physiological and metabolic status of the patients, thereby improving remission rates independent of cancer
complexity. If successful, this method will provide a promising new avenue for treating melanoma and other
types of solid tumors (e.g., breast, prostate) by significantly overcoming current immunotherapy barriers.

Public health relevance
Project Narrative This project will investigate the ability of combined calreticulin-nanoparticle (CRT-NP) and focused ultrasound (FUS) treatment to improve immunotherapy efficacy in melanoma bearing obese mice. Our published data has shown that FUS/CRT-NP (CFUS) combination upregulated CRT expression and enhanced tumor infiltration of activated and cytotoxic immune cells, resulting in excellent tumor control in lean mice. A similar demonstration of CFUC efficacy in obese mice with immunosuppressed microenvironments will support clinical development and future design of phase I human trials.